Training Program in Cancer Prevention and Control and Cancer Health Equity (CPC-CHE)

PROJECT SUMMARY
This is a competitive renewal of the NCI T32 Cancer Prevention and Control and Cancer Health Equity (CPC-
CE) Training Program at the Massey Cancer Center (MCC) at Virginia Commonwealth University (VCU). The
training program has been active for three 5-year cycles – first as an R25 and, in 2018, successfully transitioned
to a T32. The present training application has a renewed focus on cancer health equity and reducing cancer
disparities to meet the needs of MCC's catchment area and align with MCC's center-wide theme. MCC's
catchment area is diverse and includes “hot spots” of elevated cancer risk in rural and minority communities,
with several counties having elevated age-adjusted cancer rates. This unique catchment area serves as a
backdrop for research and training being conducted within rural and urban communities and among a diverse
residential population. As the longest-standing NCI-funded T32 training program at MCC, the CPC-CHE program
is highly valued by the institution and supported in matching funds by VCU, MCC and the School of Medicine.
The program brings together 25 primary and 6 secondary mentors from 12 departments across three
schools/colleges. During the current funding period, 33% of the trainees were from racial/ethnic groups
underrepresented in biomedical and behavioral science and 90% were female. One-hundred percent of the
predoctoral trainees secured postdoctoral training positions and four out of five postdoctoral trainees who have
completed the program are in academic/research faculty positions and the other is working in a non-profit
research-related career. The proposed T32 has four objectives: 1) offer an integrated training program with a
broad range of research opportunities in cancer prevention and control and/or cancer health equity, including an
option to complete a concentrated Master of Science or public health degree; 2) provide structured didactic
training in cutting-edge research methods to support career advancements in cancer prevention and control and
cancer health equity science; 3) cultivate a collaborative community that will form the foundation for effective
professional development and career readiness; and 4) provide training to emerging scholars from diverse socio-
economic and racial/ethnic backgrounds through intensive mentoring. The program requests support for two
predoctoral and five postdoctoral trainee slots. The selection of seven scholars will allow for an approximate 4:1
mentor/trainee ratio.

Public health relevance
PROJECT NARRATIVE The T32 Cancer Prevention and Control and Cancer Health Equity (CPC-CHE) program is one of the longest- standing NCI-funded training programs at the Massey Cancer Center at Virginia Commonwealth University. It has a proven history of training successful investigators in cancer prevention and control and cancer equity science. The program’s focus on cancer health equity science fills a gap in the field by training a cadre of new investigators to further science in this area.